Neural Correlates of Discourse Processing in Adolescents

PROJECT SUMMARY
About 60% of children can’t read proficiently, which is concerning as reading comprehension (RC) is linked to
educational, vocational, and health outcomes. While a robust neurocognitive literature exists on word-level
processes, a necessary but not sufficient skill for RC, similar studies at the discourse level (i.e., while reading
passages/connected text) are largely absent in developing readers. This proposal tackles this needed research
by systematically interrogating how adolescents’ neural variations during situation model formation (or building
mental models while reading) results in RC success/failure. A critical consideration for such research is that
texts are not monolithic, even though they are often treated as such: they vary by granular text features (e.g.,
word frequency) and by their superstructures, or whether a text is narrative (NarrT, stories) or expository
(ExpT, informational text such as science passages). This is important, as ExpT is central for learning new
material, while NarrT for socio-emotional growth. Notably, NarrT RC is easier than ExpT RC, a phenomenon
which is poorly understood and not explained by granular text feature differences. Building upon our initial
neurocognitive findings, along with existing theoretical and empirical work, we use neuroimaging coupled with
behavioral methods to garner insights as to where (in the brain), when (at which text junctures), and thus how
NarrT vs ExpT RC breaks down. Initial findings suggest that while both NarrT and ExpT rely on shared
neurocognitive processes, they have distinctions that may be key for enhancing RC. NarrT uniquely relies on
regions in a neural network linked to socio-emotional processes (e.g., dorsomedial prefrontal cortex), while
ExpT uniquely relies on regions in a neural network that supports executive function/cognitive control (e.g., left
dorsolateral prefrontal cortex). Our overarching hypothesis is that readers’ use of SocEMDMN vs FPN is a critical
determinant of proficient situation model formation, and, thus, RC. We also posit that the enhanced socio-
emotional NarrT context provokes greater connectivity between DisPDMN and SocEMDMN at key junctures in text,
resulting in enriched intrinsic access to readers’ internal states, and thus a neurocognitive benefit for RC.
Critically, pilot findings suggest that this enhanced socioemotional context can also be achieved in ExpT by
embedding high emotion words [words with high arousal ratings] in ExpT, perhaps paving the way to bolster
ExpT RC. Given that RC is a central avenue for learning new information after ~3rd grade, we are addressing a
highly significant public health issue. To systematically test our hypotheses, we target 10-12 yo (N=220) who
have crossed into the “reading to learn” stage to examine dynamic neural processes of ExpT vs NarrT online
reading (situation model building; Aim 1); how readers’ individual differences (e.g., executive function, socio-
emotional) modulate Aim 1’s findings (Aim 2); how Aims 1 & 2’s neural findings predict RC (Aim 3a); and, if
enhancing the socioemotional context helps RC (Aim 3b). Our ultimate goal is to identify the best ways
adolescents learn new information while reading so as to maximize academic success and prevent RC failure.

Public health relevance
PROJECT NARRATIVE Despite the fact that a substantial number of children struggle with reading comprehension (RC), and that schools prominently focus on having adequate RC for various types of texts, including stories and informational text, there is scant knowledge about the neurocognitive correlates of RC for different text types, or how readers process texts for optimal RC. This project aims to determine which brain networks are: (1) differentially linked to various text types and reader profiles and (2) predict optimal RC outcomes in children ages 10-12. Our ultimate goal is to understand the best way for children to learn new information through reading so that we can better understand how to effectively individualize instruction in a way that maximizes academic success and prevents academic failure.